RECEPTORS ON GASTRIC SMOOTH MUSCLE CELLS

In vitro systems are being used to identify receptors on gastric smooth muscle cells by means of radiolabelled ligands, agonists and antagonists, and to examine the mechanisms by which agonists exert their effects.